Health IT to reduce disparities in risks for sleep-related infant deaths

PROJECT SUMMARY/ABSTRACT
This proposal is in response to PAR19-093, and its aims are consistent with NIMHD and OBSSR priorities.
This research will examine how a unique health information technology (HIT) tool impacts patient and provider
outcomes when implemented in a pediatric primary care clinic serving a socioeconomically disadvantaged
population that is primarily Black/African American.
Aim 1. To test the impact of implementing a new EMR-based Infant Sleep Assessment (ISA) and brief
communication training on a) pediatric clinicians’ delivery of anticipatory guidance (both positive and
unintended negative consequences); and b) parents’ satisfaction with care, infant safe sleep knowledge,
beliefs, reported practices, and observed infant sleep environments.
Aim 2. To assess how implementing the new EMR-based ISA and brief communication training is perceived by
pediatric clinicians in terms of its advantages, disadvantages, and impact on their delivery of anticipatory
guidance.
For Aim 1, a randomized controlled trial will compare outcomes between a Standard of Care (SOC) and an
ISA group. Each of 12 half-day clinic sessions will be randomly assigned to SOC or ISA. Clinicians (N=88) and
the parents of their newborn patients (N=188 per study group) will remain in their assigned group throughout
the study. The ISA group will complete the tool at their 2-month well-baby visit, and both groups will have this
visit audio recorded. Follow-up data will be collected by an in-home survey and observation when the infant is
3-4 months old. For Aim 2, a brief survey will be completed by the clinicians at the end of their study
participation. Results will be disseminated through peer-reviewed publications, presentations and summary
briefs distributed through electronic media to the pediatric, injury prevention, public health, clinical informatics,
and health disparities communities.

Public health relevance
PROJECT NARRATIVE This work will result in having an elegant health information technology package for infant safe sleep – Infant Sleep Assessment and Best Practice Advisory – along with a training module for enhancing pediatricians’’ counseling skills. If found to be effective the HIT tools can be widely disseminated as it uses the Epic platform, an electronic medical record system used by a majority of US health care facilities. Together this program offers a feasible and potentially effective way to maximize the utility of pediatric well baby visits to promote safe infant sleep.